Structural studies of RNA processing and ubiquitin-like protein modification

RNA decay. The balance between RNA transcription and degradation contributes to regulation of RNA
lifetime, quality and abundance. Two principle RNA decay pathways exist in eukaryotes, one degrades RNA 5’
to 3’ while the other degrades RNA 3’ to 5’. The 3’ to 5’ decay pathway requires activities of the RNA exosome,
a multi-subunit protein complex that contains a nine-subunit non-catalytic core and two additional subunits that
catalyze processive and distributive 3’ to 5’ RNA exoribonuclease activities. Ten of the eleven genes are
essential for life in budding yeast, suggesting the importance of the RNA exosome and its activities in cellular
function. In addition, reports over the last several years suggest that humans harboring mutations in select
components of the 3’ to 5’ decay pathway suffer from diseases ranging from motor neuronopathies to cancer.
Fundamental aspects of eukaryotic exosome structure and function have been illuminated; however, many
questions remain with respect to how upstream factors target substrates for degradation. As RNA decay
pathways play a fundamental role in eukaryotic nucleic acid metabolism and disease, our studies are directly
relevant to human health and the NIH mission as misregulation of RNA decay is associated with cancer,
inflammation and neurodegeneration. This renewal will address central issues of RNA exosome biology by
reconstituting or purifying RNA exosomes and upstream factors for characterization through biochemical,
genetic and structural studies to establish functions for 3’ to 5’ decay in vitro and in vivo.
Ubiquitin-like proteins. Signal transduction can rely on reversible chemical modifications to relay information.
Protein substrates can be covalently modified by ubiquitin and ubiquitin-like proteins such as SUMO (small
ubiquitin-like modifier) to regulate processes such as nuclear transport, cytokinesis, chromosome segregation,
G2-M cell cycle progression and transcription. Post-translational modification by ubiquitin (Ub) and ubiquitin-
like (Ubl) proteins requires the sequential action of E1 activating enzymes, E2 conjugating enzymes and E3
protein ligases while Ub/Ubl processing and deconjugation is catalyzed by Ub/Ubl-specific proteases. Ubiquitin
and SUMO conjugation play integral roles in eukaryotic nuclear metabolism and cell cycle control and our
studies are of direct relevance to human health, cancer, and the mission of the NIH. This renewal seeks to
address the functional significance for components of the ubiquitin and SUMO conjugation pathways through
structural, biochemical and genetic studies that will establish a basis for Ub/Ubl activation, conjugation by E2
and E3 enzymes, and signaling through characterization receptors that recognize Ub/Ubl-conjugated
substrates. The enzymes, mechanisms and cofactors utilized for ubiquitin and SUMO protein conjugation
pathways are conserved so our studies are broadly relevant to other Ub/Ubl-related pathways.

Public health relevance
RNA abundance and lifetime is regulated by fundamental processes that includes the eukaryotic RNA exosome and its upstream cofactors, essential multi-subunit complexes that contribute to RNA homeostasis through 3’ to 5’ processing and degradation in surveillance pathways that monitor the quality of nuclear and cytoplasmic RNA and in signaling to control the duration of RNA expression. Post-translational protein modification by ubiquitin (Ub) and ubiquitin-like (Ubl) proteins such as SUMO (small ubiquitin-like modifier) regulate protein activities in processes that include the cell cycle, protein degradation, protein localization, nuclear transport, cytokinesis, chromosome segregation, and transcriptional regulation. This proposal seeks to continue exploration of these essential eukaryotic processes of Ub/Ubl-protein modification and RNA decay through structural, biochemical and genetic studies that will illuminate molecular mechanisms underlying defects associated with human diseases that include cancer, inflammation, and neurodegenerative disorders.